DIVISION OF CANCER PREVENTION, INFORMATION TECHNOLOGY AND INFORMATICS SUPPORT

This requirement provides information Technology and Informatics support for DCP (e.g., database administration, data reporting, SharePoint administration, and other informatics programming).